Structural studies of function and regulation of microtubules and transcriptional gene expression machinery

PROJECT SUMMARY/ABSTRACT
We are dedicated to deciphering the molecular mechanisms central to two essential processes:
transcriptional regulation of gene expression and chromosome segregation by the microtubule (MT) cytoskeleton
during cell division. We are using cryo-EM to visualize the molecular players critical to those processes.
Gene transcription is a complex task, critical for growth and survival. While initiation is the most regulated
step in transcription, and its fine-tuning can produce organism-wide changes in gene expression profiles, a
mechanistic understanding lags behind due to the complexity of the molecular machinery involved. In addition
to the RNA polymerase II (Pol II), general transcription factors (GTFs: TFIIA, TFIIB, TFIID, TFIIE, TFIIF, TFIIH))
are required to find the transcription start site (TTS) and to melt and load the DNA onto Pol II. TFIID (~ 1 MDa)
is required for binding to different core promoter sequences and for activated transcription. TFIIH (~450 kDa) is
essential for promoter melting and the phosphorylation of Pol II needed to clear the promoter, as well as for DNA
repair. Structural analysis of the eukaryotic transcriptional machinery is extremely difficult due to its scarcity, poor
stability, and its intrinsic flexibility. My lab has made substantial progress in describing the architecture and DNA
interactions of human TFIID, and visualizing the human transcription preinitiation complex (PIC) of GTFs in
different states, uniquely contributing to establishing a structural framework for the transcription initiation process.
We are now well poised to make further contributions to this field. We will define the atomic structures of TFIID
and TFIIH, which lag behind, and build complexity by adding gene-specific transcription factors to our human
PICs in order to provide insights into the structural basis of transcriptional regulation.
Cell division is a complex, highly regulated process in which the microtubule (MT) cytoskeleton plays a central
role, serving as energy source for dramatic chromosomal movements and acting as a scaffold that facilitates
molecular encounters at the right time and place. Essential for MT function is dynamic instability, a property that
can be both regulated and utilized for cellular work. The MT is built by the self-assembly of ab-tubulin dimers
and MT dynamics are due to the coupling of the assembly process to GTP hydrolysis in b-tubulin. Anticancer
drugs like taxol stop cell division by interfering with MT dynamics, while many MT cellular partners modulate
or utilize dynamic instability to carry out specific functions. By characterizing in atomic detail the
conformational changes in MTs that accompany GTP hydrolysis, my lab has shed unique light into the structural
basis of MT dynamic instability. We have also visualized the binding site and effect of anticancer drugs on MTs,
and started to define how cellular factors interact with the MT surface, potentially affecting its structure and
stability. Our main effort now is to extend our knowledge on the binding and effect of mitotic factors that regulate
MT dynamics and organization, and shed mechanistic light into a fundamental process for the eukaryotic cell
that will contribute to the improvement/development of anticancer agents that interfere with mitosis.

Public health relevance
PROJECT NARRATIVE We use cryo-EM for the visualization of macromolecular complexes involved in chromosome movement and the regulation of gene expression, and have uniquely contributed to describe human transcription initiation complexes and microtubules. We will now structurally characterize how cellular factors regulate microtubule assembly, dynamics and organization, especially during mitosis. We will also produce atomic models of TFIID and TFIIH and define how gene-specific transcription factors regulate DNA binding and assembly of the transcription preinitiation complex.